Revitalization of the DEHS Assessment Program

Project Summary for Colorado's Retail Food Program Proposal to Revitalize the Assessment Program in harmony with Standard 9, Program Assessment of the Voluntary National Retail Food Regulatory Program Standards It is the intent of the Colorado Department of Public Health and Environment's Division of Environmental Health and Sustainability to use this opportunity to revitalize the assessment program to be in harmony with Standard 9, Program Assessment, create a sustainable program that will result in local retail food programs being trained in the standards and assessment program, and conduct assessments of over thirty local retail food programs throughout the state. Our goal is to ensure that Division staff working within the assessment program is well trained, knowledgeable and will consistently and uniformly apply that knowledge to the future assessments to be conducted with local regulatory programs. To date we have used the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS) as the standard to evaluate the various aspects of our program and have identified gaps with the standards that have not been met. We are moving forward with formulating an action plan to address these gaps and strengthen and improve our program. Establishing a solid program foundation will help improve the program now, provide guidance for the future, and promote a program that will be a model for other Colorado local retail food inspection programs. The goal is to have the work conducted by all of Colorado's retail food inspection programs be recognized for their quality and consistency related to inspections, sound program practices, and targeted efforts in reducing the occurrence of foodborne illness risk factors. This will assist the state in meeting its Winnable Battle of Safe Food geared at providing safe food to Colorado residents and guests. The agency is committed to help achieve FDA's goal of an integrated food safety system and ensure that Colorado's inspections, investigations, assessments and program initiatives are recognized as model programs nationwide.

Public health relevance
Project Narrative for Colorado's Retail Food Program Proposal to Revitalize the Assessment Program in harmony with Standard 9, Program Assessment of the Voluntary National Retail Food Regulatory Program Standards Colorado's proposed project to revitalize Assessment Program within the Division of Environmental Health and Sustainability, Delegated Program Unit and work to conform to the VNRFRPS will ensure that trained, qualified staff will conduct assessments of local retail food inspection programs in the state and promote national food safety standards focused on reducing the occurrence of foodborne illness risk factors in retail food establishments. __SpecificAimsTextDelimiter__ Specific Aims for Colorado's Retail Food Program Proposal to Revitalize the Assessment Program in harmony with Standard 9, Program Assessment of the Voluntary National Retail Food Regulatory Program Standards Goals of Proposed Project " DEHS will update assessment protocols to harmonized with Standard 9. " Update the current retail food inspection database to allow full development of an assessment tracking system to capture elements of Standard 9, generate reports with data pertinent to the Risk Factor Study, allow analysis of program effectiveness in reducing the occurrence of foodborne illness risk factors. " Conduct assessments of over thirty local retail food regulatory programs. " Conduct reassessments of ten local retail food regulatory programs. " Achieve full conformance with standards as well as annual review of established protocols and policies to ensure they remain current, applicable and effective. " Allow staff to attend FDA recognized training courses on VNRFRPS, National and Colorado conferences and meetings addressing VNRFRPS initiatives, and the time it takes to ensure staff are fully trained and competent. " Participate on committees through face-to-face meetings, conference calls, and other means to further our progress on the standards. Summary of Expected Outcomes " Enrollment in VNRFRPS of at least 15 local retail food inspection programs. " Complete assessments of over 30 local retail food inspection programs. " Complete reassessments of 10 local retail food inspection programs. " Strategies developed for achieving and sustaining reassessments and conformance with Standard 9, for local retail food programs. " Achieve and sustain significant to full conformance with the VNRFRPS; one of the key elements of a nationwide fully integrated food safety system. " Facilitate continuous improvement to the VNRFRPS by actively participating at the annual meetings, workgroups and nationwide committees developed to support the VNRFRPS. Result of Proposed Project Colorado's Retail Food Regulatory Program will harmonize an assessment program with Standard 9 that will be sustained beyond the completion of the grant. This will provide local retail food programs with a baseline to identify and measure program improvements; creating greater protection of public health from foodborne illness associated with retail food products. The goal is to have work conducted by all retail food programs in Colorado's recognized for quality and consistency in reducing the occurrence of foodborne illness risk factors. This will allow Colorado to meet its Winnable Battle of Safe Food. The agency is committed to help achieve FDA's goal of an integrated food safety system and ensure that Colorado's inspections, investigations, assessments and program initiatives are recognized as model programs nationwide.